Dietary methionine restriction as a therapeutic strategy for metastatic melanoma

Project Summary – Project Leader Isabelle Racine Miousse
Nearly 10,000 Americans die from melanoma every year. Since 2011, immune checkpoint inhibitors have
been approved for metastatic melanoma. These antibodies enhance a person’s immune system ability to
recognize cancer cells. Despite a major improvement in remission rates, the majority of patients do not respond
to immune checkpoint inhibitors. The identification of approaches to overcome immune checkpoint inhibitor
resistance, as well as new therapeutic strategies to treat metastatic melanoma, are crucially needed.
Cancer cells rely on exogenous sources of methionine, contrarily to normal cells that can thrive off the
remethylation of homocysteine. Our data shows that at levels that maintain body weight, a methionine restricted
diet dramatically reduces tumor size and number of lung metastases in an immunocompetent murine melanoma
model. Our preliminary data indicates that the effect involves mitochondrial function. Recent work highlighted
the importance of mitochondrial function in immune checkpoint inhibitor responders versus nonresponders. The
combination of methionine restriction and immune checkpoint inhibitor responsiveness has never been tested.
In addition to direct effects on methionine dependent cancer cells, we have determined that alterations in dietary
methionine affect the gut microbiome. It is now well-established that there are significant differences in the gut
microbiomes of patients with metastatic melanoma that are associated with efficacy of immune checkpoint
inhibitor therapy, and that responsiveness can be induced with fecal transplantation in animal models. However,
the impact of a methionine-regulated microbiome on melanoma growth, metastasis, and immune checkpoint
inhibitor responsiveness is unknown.
According to our data and supporting scientific literature, we hypothesize that dietary methionine restriction
will promote antitumor mechanisms, including autophagy and microbiome alterations, which will increase
immune checkpoint inhibitor responsiveness for metastatic melanoma. To test this hypothesis, we propose to
study the effect of a methionine restricted diet in a preclinical, immunocompetent mouse model of melanoma.
Following establishment of tumor, mice will receive a standard diet or an identical diet containing low levels of
methionine to investigate the following: Aim 1) Determine whether methionine restriction increases
responsiveness to immune checkpoint blockade in a preclinical mouse model. Aim 2) Determine the contribution
of gut microbiota in methionine-dependent antitumor activity.
Our study investigates a novel approach to decrease mortality due to metastatic melanoma. We expect the
results generated from our studies to be translatable to other types of malignancies, especially those for which
immune checkpoint inhibitors are used for therapy.